A systems approach to uncover upstream activators and common downstream pathways of neurodegeneration in a Drosophila model

PROJECT ABSTRACT Most neurodegenerative disorders exhibit highly heterogeneous genetic underpinnings. For example, with Alzheimer's disease (AD), amyotrophic lateral sclerosis (ALS), frontotemporal lobar degeneration (FTLD) and Parkinson's disease (PD), mutations in different genes are causal in distinct subsets of families. In addition to this genetic heterogeneity among inherited cases, the majority of individuals exhibit sporadic forms of these disorders in which there are no known causal mutations. In part because of this sporadic onset, it is widely accepted that (largely unknown) environmental forces are at play in the initiation and/or progression of each of the above disorders. This proposal will use a systems approach in Drosophila to identify forces that drive initiation, as well as common cellular responses that may modulate progression. This will be accomplished by three scientific aims. First, we will test a series of cellular stressors, behavioral stressors, and models of injury/inflammation. The effects of these manipulations will be assayed by following 7 different neurodegenerative phenotypes and biomarkers, including a novel assay of endogenous retrovirus replication. Second, we will use a relatively new approach to purify the population of cells that are most impacted, and profile active transcription within the nuclei. This experiment will identify common downstream cellular responses. Finally, we take advantage of high throughput genetic approaches in Drosophila to systematically test for functional impact of identified gene targets.

Public health relevance
PROJECT NARRATIVE Although genetics can play an important role in most neurodegenerative disorders, most cases are sporadic in origin, meaning that no family history exists and no known genetic cause has been identified. It is thought that environmental forces impact the onset and perhaps progression of neurodegeneration. This likely is true for Alzheimer's disease, Parkinson's disease, amyotrophic lateral sclerosis, and frontotemporal lobar degeneration. This proposal will use a systematic approach in Drosophila to identify environmental and lifestyle perturbations that impact a series of neurodegenerative biomarkers and phenotypes. In addition, we will seek to identify common downstream cellular impacts that are shared across relevant environmental perturbations.